PDB MANAGEMENT BY THE RESEARCH COLLABORATORY FOR STRUCTURAL BIOINFORMATICS

Administrative Supplement Request in Response to PA-20-272 Parent Award Identifier: 1R01GM133198 Parent Award Title: PDB Management by the Research Collaboratory for Structural Bioinformatics Parent Award Principal Investigator: Stephen K. Burley, M.D., D.Phil. Supplement Request: Containerization of RCSB PDB Backend Services for RCSB.org Project Summary/Abstract: In its role as a core NIH data repository, the Research Collaboratory for Structural Bioinformatics Protein Data Bank (RCSB PDB) is committed to the best practices articulated by the FAIR and TRUST principles. Established in 1971 as the first open-access digital data repository in biology, the PDB has been a leading exemplar of FAIR. RCSB PDB was also an early adopter in securing CoreTrustSeal certification and advocating for the TRUST principles. In this supplement, we are requesting funding to containerize RCSB PDB Backend Services for RCSB.org to improve user access with scalability of these services using Docker Containers and Kubernetes Orchestration hosted on RCSB PDB-owned on premises hardware.

Public health relevance
Project Narrative: In its role as a core NIH data repository, the Research Collaboratory for Structural Bioinformatics Protein Data Bank (RCSB PDB) is committed to the best practices articulated by the FAIR and TRUST principles. This project will extend further RCSB PDB support of the FAIR principles by containerizing RCSB PDB Backend Services for RCSB.org to improve user access with scalability of these services using Docker Containers and Kubernetes Orchestration hosted on RCSB PDB-owned on premises hardware.